Novel Insights into the Role of Prions in Polyglutamine Protein Homeostasis

Abstract
Formation of toxic protein aggregates is a hallmark of neurodegenerative disorders. In some diseases, including
Huntington’s Disease and six subtypes of spinocerebellar ataxia, protein aggregates form due to the expansion
of a CAG repeat in the coding region of a specific gene. This CAG repeat encodes for a polyglutamine tract that
aggregates when expanded, leading to neuronal death. One potential way to treat these diseases is to suppress
polyglutamine aggregation and toxicity. Our laboratory has taken a unique approach to addressing this issue.
Instead of studying polyglutamine in organisms where it aggregates and causes toxicity, we have identified the
social amoeba Dictyostelium discoideum as a proteostatic outlier that is naturally resistant to polyglutamine
aggregation. To investigate this phenomenon, I conducted a proximity labeling screen to identify proteins in
Dictyostelium with increased proximity to polyglutamine-expanded huntingtin, the causative protein in
Huntington’s Disease. Strikingly, I found that many proteins with increased proximity were highly glutamine-rich
and predicted to form prion. This is interesting because prions influence polyglutamine aggregation in a poorly
defined manner. Here I propose to help clarify the role of prion-like proteins in Dictyostelium and their potential
role in suppressing polyglutamine aggregation. Using parallel investigation in Dictyostelium, human cells, and in
vitro experiments, I hope to elucidate the role of prion-like proteins in regulating polyglutamine aggregation.
Additionally, I propose to define the roles of prions in Dictyostelium biology. Together these aims begin and
define the roles of prion-like proteins in Dictyostelium and determine how they influence the solubility of
Dictyostelium’s polyglutamine-rich proteome.

Public health relevance
Project Narrative: Protein aggregation is a hallmark of neurodegeneration and is the cause of the nine polyglutamine diseases. The goal of my proposed project is to use both genetic and biochemical approaches to discover factors that suppress polyglutamine aggregation in Dictyostelium discoideum, an amoeba that is uniquely resistant to this phenomenon. Once identified, these factors may be utilized to aid in the development of novel therapies for these incurable diseases.